Autonomous Monitor for Toxic Gas Exposure

Project Summary
The overall goal of this SBIR project is to develop a miniature, microfabricated gas
chromatography (micro GC) device for autonomous, near real-time monitoring of toxic VOCs
(volatile organic compounds) in the workplace. A key differentiator is exploring a low-cost
multilayer fabrication process to develop a new-type micro GC. Through the Phase I project, a
working prototype of the proposed micro GC has been created and has demonstrated rapid and
sensitive measurement of representative toxic VOCs in air. This Phase II study will further
optimize the designs and fabrication of key micro GC components developed in Phase I and
create a commercial prototype. Micro GC method development and validation for additional toxic
VOCs, as well as pilot testing, will also be pursued in Phase II. The final product will be a plug-
and-play toxic VOC monitor with online sampling and onboard calibration capabilities.
Toxic or even carcinogenic VOCs can be emitted into the workplace and environment from
many industrial and chemical processes, posing a serious health hazard to workers as well as
the general public. Therefore, there is a critical need for sensitive and accurate monitoring of VOC
exposure in real time or near real time. Unfortunately, existing approaches are associated with
major limitations due to the lack of specificity (e.g., colorimetric detection tubes and
photoionization sensors), or because of the requirement of a bulky/expensive instrument or offline
sampling (e.g., traditional GC methods). The proposed micro GC aims to overcome these
drawbacks and address the critical needed for autonomous, continuous, and specific monitoring
of VOC exposure.

Public health relevance
Project Narrative Many volatile organic compounds (VOCs) are recognized as toxic or even carcinogenic hazards. The proposed instrument will help protect workers as well as the general public by providing near real-time monitoring of such VOCs in the workplace and the environment.